Setting Priorities to Advance Clinical and Research Efforts in Nerve Injury - Nerve SPACE

ABSTRACT
This is a request to support the inaugural Nerve SPACE (Setting Priorities to Advance Clinical and Research
Efforts in Nerve Injury) Conference, which will be hosted at Washington University Medical Center in St. Louis,
MO in Q2 2025. Washington University has a distinct history of innovation and achievement in nerve injury and
reconstruction, with internationally-recognized experts tracing lineage to the nerve programs in Plastic Surgery,
Neurosurgery, and Orthopaedic Surgery, and is therefore uniquely position to host the inaugural Nerve SPACE
meeting. Function of the musculoskeletal system is suddenly disrupted by nerve injuries. To restore function of
the musculoskeletal system, patients with nerve injuries are cared for by hand surgeons, orthopaedic surgeons,
plastic surgeons, and neurosurgeons. This broad coalition of disciplines provides the opportunity to gather a
diverse and inclusive group of perspectives on the diagnosis, prognosis, clinical care, and research priorities for
nerve injuries. The purpose of the Nerve SPACE conference is to gather nerve surgeons, established and
emerging researchers, and other stakeholders (therapists, physiatrists, neurologists, patient advocates, and
industry contacts) to discuss current controversies and future directions for clinical care and research in
peripheral nerve injury. There will be an emphasis on open discussions, forward thinking, exploring cutting-edge
findings, and building consensus.

Public health relevance
NARRATIVE This is a request to support the inaugural Nerve SPACE (Setting Priorities to Advance Clinical and Research Efforts in Nerve Injury) Conference, which will bring together nerve surgeons, researchers, and stakeholders who are mutually dedicated to improving upper and lower extremity function and quality of life after nerve injury. The Nerve SPACE conference will allow both established experts and emerging researchers the opportunity to exchange ideas and foster collaboration in an intimate and collegial setting. The overarching goals of the Nerve SPACE conference will be to build consensus on knowledge gaps to and to identify areas for short-term and long-term focus for clinical and research efforts and resources.